ENZYO, AN ONTOLOGY OF ENZYMES INVOLVED IN GLYCAN METABOLISM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Enzyme activity plays a crucial role in the synthesis of glycans. However, we believe that enzymes, as a subset of proteins, and the reactions that they catalyze form a separate domain of interest. For this reason, rather than extending our glycomics ontology GlycO, we are enriching it through the development of a domain specific ontology, EnzyO (for Enzyme Ontology).